Role of BK channels in alcohol-induced dysmyelination

SUMMARY
Myelination is essential to efficient action potential propagation and neuron survival. The bulk of myelination
occurs during development, but new myelin sheaths continue to be added throughout adulthood, especially in
white matter tracts. Chronic alcohol exposure alters the expression of myelin genes/proteins and reduces the
volume and microstructural integrity of white matter tracts both in humans and in animal models. However, the
molecular and cellular mechanisms driving these effects are poorly understood. The present project seeks to
address the structural and functional correlates of myelin protein changes in a mouse model of alcohol use
disorder that combines voluntary alcohol drinking and chronic intermittent alcohol vapor inhalation. One goal is
to tease apart the effects of alcohol on oligodendrogenesis vs. preexisting myelin using in vivo genetic labeling
of newly formed myelin and in vitro assays of oligodendrocyte precursor cell differentiation. In all experiments,
we will test the role of ethanol's action at large conductance, voltage- and calcium-activated potassium channels
(BK channels) using knockin mice that express ethanol-resistant BK channels. Potential sex differences will be
considered throughout the project. The first Aim will use untargeted quantitative proteomics to determine whether
chronic alcohol and withdrawal impact the abundance of myelin proteins differentially in female vs. male brain
samples. The second Aim will use electroencephalography to measure the functional integrity of myelin over
time and electron microscopy to analyze the ultrastructure of myelin sheaths at timepoints of peak deficit and
recovery onset. The third Aim will use a mouse reporter line to quantify the formation of new myelin and
oligodendrocytes during alcohol exposure. The fourth Aim will use primary cultures to determine whether the
effects of alcohol on oligodendrogenesis are caused by a direct action on oligodendrocyte lineage cells or via
extrinsic mechanisms involving other brain cell types. This project builds on rigorous evidence of the pervasive
effects of alcohol on myelin. It is innovative because the molecular target of ethanol responsible for myelin
disruption is unknown and the role of BK channels in oligodendrogenesis is uncharted. The proposed research
will enhance our mechanistic understanding of alcohol's effects on myelination and may in turn create
unprecedented opportunities for prevention and/or restoration strategies.

Public health relevance
NARRATIVE This research project investigates the effects of chronic alcohol exposure on the structure, function, and formation of the myelin sheaths that insulate neuronal fibers in the brain. It will test the role of a potassium channel sensitive to alcohol. This work aims to enhance our understanding of the molecular and cellular mechanisms responsible for the deterioration of white matter in alcohol use disorder.